The Role of Cytoplasmic and Nuclear THEMIS in Immature and Mature T cells

Abstract
THEMIS associates with a growing number of inflammatory diseases in humans, including Celiac Disease,
Multiple Sclerosis and Atopic Dermatitis. THEMIS associated disorders affect different anatomical sites and
follow different pathogeneses, placing THEMIS as one of the core “inflammatory”-controllers. Despite the strong
association of THEMIS with multiple inflammatory diseases in humans and the profound defects in T cell
development and selection in THEMIS-deficient mice, the function of THEMIS and the pathways or factors it
interacts with remain enigmatic. THEMIS1 is expressed in T cells where it functions as a key adaptor downstream
of the TCR. In thymocytes it is essential for positive selection leading to the generation of naïve T cells. THEMIS
continues to be expressed in mature CD8ab and CD4 TCRab T cells but its role in mature T cells is not known.
Moreover, THEMIS is expressed in the nucleus as well as in the cytoplasm and although THEMIS, as a TCR
adaptor, has been well studied, it’s role in the nucleus remains undefined and nothing is known about the
significance of this differential subcellular localization for its function in thymocytes or mature T cells. These
significant gaps in our understanding of the biology of THEMIS greatly impede on the progress to identify the
role of THEMIS in those diseases it is associated with or to design effective strategies to target THEMIS for the
treatment of inflammatory diseases or to enhance protection against infections and cancers. The proposal here
sets out to address these significant gaps with the use of unique new tools to examine THEMIS in the cytoplasm
and nucleus of immature and mature T cells.

Public health relevance
Project Narrative T cells are key players in immune responses that are essential to protect the host against a variety of pathogens and cancers. In some cases, their uncontrolled activity can also lead to pathologies such as inflammatory or autoimmune diseases. It is thus essential to understand the mechanisms underlying their activation and regulation. This activation is mediated by the T cell receptor, which when triggered, leads to a cascade of intracellular events involving several molecules. In this proposal we will investigate how the molecule, THEMIS and the mechanisms it employs, regulate the function of T cells.